TRANSFORM: Engagement Core

ABSTRACT – Community Engagement Core (CEC)
The overarching goal of the Community Engagement Core (CEC) is to provide effective outreach and
dissemination for TRANSFORM's evidence-based and evidence-informed knowledge to grow the next
generation of child maltreatment prevention scholars and reach a broad range of stakeholders in the child
maltreatment community. The CEC will accomplish this in collaboration with the Overall, Administrative Core,
and Research Projects through a cohesive series of activities focused on bridging maltreatment research and
practice, expanding the pool of maltreatment researchers via mentoring and research training, and leveraging
existing resources to reach large numbers of diverse stakeholders across child-serving systems. This target
audience includes students, junior investigators, child welfare leaders, and practitioners (physical and mental
health providers, attorneys, judges). TRANSFORM's CEC is fortunate to build on three highly successful
existing research facilities at University of Rochester (Mt. Hope Family Center, Laboratory for Interpersonal
Violence and Victimization, and the Susan B. Anthony Center), and University of Minnesota Institute for
Translational Research in Child Mental Health; both institutions already include dissemination and outreach in
their current missions and portfolios. TRANSFORM will leverage existing funding, but more importantly,
existing reach and uptake, and extend current activities to disseminate work nationally via webinars, social
media, publications and presentations at national meetings, as well as hosting summer research institutes and
national and local events. The foci of dissemination and outreach efforts include: (i) a multiple-levels-of-
analysis framework in understanding the impact of maltreatment on children (i.e., the importance of
recognizing the impact of maltreatment on a broad range of bio-behavioral functioning across development,
including epigenetic findings); (ii) evidence-based screening and interventions to identify, and prevent and
ameliorate the impact of maltreatment on child adjustment and development, and (iii) systems approaches to
working with maltreated/traumatized children (i.e., trauma-informed practice), across the fields of mental
health, medicine, and law. The CEC will award pilot funds to junior scholars to launch careers, matching the
award with a senior scholar mentor. The CEC's multifaceted approach brings to bear a new way of considering
dissemination: a three-dimensional approach across multiple professions, geographical locations, and social
media platforms.